Development of integrated OCT/US/PAT system for intravascular Imaging

PROJECT SUMMARY
Coronary artery disease (CAD) is the most prevalent cardiovascular disease, impacting over 18 million
adults and causing more than 350,000 deaths annually in recent years. Acute coronary events are primarily
caused by ruptured atherosclerotic plaques, emphasizing the need for early detection and accurate identification
of plaque types (stable versus vulnerable) as the first line of defense. Obtaining detailed morphology and
functional information on atherosclerotic plaques is crucial for advancing clinical management of atherosclerosis.
The objective of this proposal is to develop a single intravascular imaging system incorporating
intravascular ultrasound (IVUS), photoacoustic tomography (PAT), optical coherence tomography (OCT), and
polarization-sensitive OCT (PSOCT) to study and characterize plaque vulnerability. The multimodal imaging
probe, requiring only a single disposable guide wire and catheter, aims to reduce costs, risks, procedure time,
and radiation exposure. Building upon integrated IVUS/OCT and IVUS/PAT technology developed in our lab, the
proposed OCT/US/PAT system includes significant advancements for enhanced clinical translation. It combines
the high molecular sensitivity of PAT at 1720 nm, broad imaging depth of US, high spatial resolution, and
extended penetration depth of 1.7-μm OCT, along with mechanical evaluation using PSOCT. The system
provides physicians with a powerful clinical instrument for studying, diagnosing, and managing vulnerable
plaques. The specific aims are to: 1) Design and construct a multimodal confocal OCT/US/PAT imaging probe;
2) Design and develop the OCT/US/PAT system using a 10-kHz, 1720 nm pulsed laser for PAT and a 100-kHz
swept-source laser for OCT/PSOCT; 3) Demonstrate the efficacy of the proposed system via in vivo porcine
model.
We expect the development of the proposed OCT/US/PAT technology to bring tremendous impact to
both basic science and clinical understanding of plaque pathogenesis. This will enhance the clinicians' ability to
identify vulnerable lesions, tailor interventional therapy, and monitor disease progression. More importantly, it
will be a powerful tool that provides a quantitative means to benchmark and evaluate new medical devices and
therapies.

Public health relevance
PROJECT NARRATIVE Coronary artery disease (CAD) is the most common type of heart-related issue, affecting over 18 million adults and resulting in more than 350,000 deaths annually in recent years. Our objective is to develop an advanced intravascular imaging system that combines the high spatial resolution of optical coherence tomography, the broad imaging depth of ultrasound, and the high molecular sensitivity of photoacoustic tomography. This system will assist doctors in detecting high-risk areas, customizing treatments, and monitoring the progression of the disease and therapeutic effectiveness. It will serve as a potent tool, offering a quantitative means to benchmark and evaluate new medical devices and therapies.